In Vivo Production of CAR-Microglia for Treating Alzheimer’s Disease

SUMMARY
Despite the current prevalence of Alzheimer’s disease (AD), there are few effective disease-modifying therapies1.
AD is characterized pathologically by amyloid-beta plaques (Aβ), neurofibrillary tau tangles, neuroinflammation,
and neurodegeneration1. Microglia, the resident macrophages in the central nervous system (CNS), constantly
patrol the CNS for damage2. In AD, microglia mount a strong pro-inflammatory immune response to Aβ4, which
is partially effective at clearing Aβ in the early stages of AD but loses effectiveness as Aβ load increases4,5.
Microglial deficiency in clearing Aβ is likely because microglia are not evolutionarily equipped with an optimal
receptor to recognize and degrade Aβ3. A known microglial receptor recognizing Aβ is the triggering receptor
expressed on myeloid cells 2 (TREM2), whose primary ligand is anionic phospholipids3,7 rather than Aβ.
Aducanumab is an FDA approved anti-Aβ monoclonal antibody that has been shown to be effective at reducing
Aβ plaques in AD.14,21. However, it also induces an excessive pro-inflammatory microglial phenotype that is
associated with brain volume loss and amyloid-related imaging abnormalities in patients21-23. Chimeric antigen
receptor (CAR) allows targeted recognition of specific antigens by immune cells and has been successfully used
to target tumors8. Because of the lack of a specific anti-Aβ microglial receptor, CAR technology likely
represents an important therapeutic strategy for AD. Traditional CAR therapy requires extensive resources
as ex vivo engineering of immune cells is needed10. We propose to use blood brain barrier (BBB) crossing lipid
nanoparticles (LNPs) to encapsulate mRNA encoding an anti-Aβ CAR and IL-10 to directly induce expression of
anti-Aβ microglial CARs and IL-10 to promote an anti-inflammatory brain microenvironment in vivo.
In Aim 1, we will develop two anti-Aβ CAR constructs that specifically detect Aβ via an aducanumab
single chain variable fragment (scFv) and promote phagocytosis via the TREM2 or Fc receptor (FcR) signaling
pathways. We will then package mRNA encoding the CARs and IL-10 in LNPs with anti-TREM2 antibody Fab
on the LNP surface to promote preferential uptake by microglia, which upregulate TREM2 in the vicinity of
plaques. We will transfect primary mouse microglia with these constructs or controls and measure phagocytosis
of Aβ and microglial activation in vitro. We will proceed with the most effective construct for in vivo studies.
In Aim 2, we will test whether the LNP-CAR can transfect microglia and reduce Aβ plaques in 5XFAD
mice in vivo. We will administer LNP-CARs by intravenous injection into 5XFAD at several timepoints during
amyloidosis. We predict LNP-CARs will effectively transfect microglia in vivo, will lead to increased microglial
recognition and engulfment of Aβ plaques, and limit neuroinflammation, dystrophic neurites, neurodegeneration,
and cognitive decline. In summary, we propose a strategy to treat AD by using cell-type specific LNPs
containing mRNA encoding an anti-Aβ CAR construct and IL-10 to induce CAR microglia and an anti-
inflammatory brain microenvironment in vivo.

Public health relevance
NARRATIVE Alzheimer’s disease is characterized by the accumulation of protein aggregates comprised initially of amyloid beta and later of abnormal tau protein. Microglia, the primary immune cells of the brain, are responsible for clearing amyloid beta but do not possess a receptor evolutionarily optimized to detect and engulf it. We propose a strategy using lipid nanoparticles to induce production of a synthetic anti-amyloid beta receptor in microglia, so that they can specifically recognize and degrade amyloid beta plaques to treat Alzheimer’s disease.